Machine learning in publicly available geotagged data to allow monitoring of maternal and child health

Over 95 percent of maternal and child deaths globally occur in low- and middle-income countries (LMICs)
where reliable death registries are mostly unavailable and other dependable data are scarce. Moreover, within
LMICs, the most disadvantaged and remote communities tend to have the highest mortality rates but the least
reliable data. Knowledge on the state of maternal and child health (MCH) in LMICs relies mostly on household
surveys. These expensive and time-consuming surveys cover merely a small minority (usually <2%) of all
communities in a country and are (at best) carried out only every couple of years. We propose a new approach
to measuring MCH indicators that would provide up-to-date estimates at a very high geographic resolution and
at little to no cost. Specifically, we hypothesize that machine learning in geotagged “big data” sources, with a
key source being satellite imagery, can accurately estimate critical MCH indicators for each village and
neighborhood in a country. Satellite imagery is a key data source in this project because it is updated
frequently (at least monthly), covers all areas of a country, and is available free of charge. We will pursue three
specific aims: 1) determining whether machine learning in satellite imagery and other publicly available
geotagged data can accurately estimate key indicators of MCH status in a village or neighborhood at a
snapshot in time and longitudinally over time; 2) determining whether this approach can also accurately
estimate coverage with critical MCH services at a snapshot in time and over time; and 3) achieving sufficient
interpretability of our machine learning models to inform on data needed to improve predictions, which
interventions to target where, and generalizability. The approach to achieving our aims is to use household
surveys that are geocoded at the village and neighborhood level as the “ground truth” against which we will
train machine learning models in satellite images and publicly available geotagged data. Our extensive
preliminary data, along with high-impact publications (e.g., in Science and Nature) by our team on using
satellite images to predict important determinants of MCH in LMICs (such as community-level poverty, surface
water quality, water and sanitation infrastructure, crop yields, travel time to the nearest healthcare facility, and
air pollution), demonstrate that this approach is feasible. Crucially, our predictions will improve over time as the
size and quality (e.g., the resolution of satellite imagery) of our data continue to increase. In addition to a
unique dataset as well as open-access code for our machine learning models, this project will provide maps
with an extremely high geographic resolution of key MCH indicators to inform policymakers and researchers on
the current state of MCH. This project is significant because it can inform the geographically precise planning
and targeting of MCH interventions, may enable the evaluation of past interventions and policies, and can
serve as a blueprint for extending a “precision public health” approach to health outcomes beyond MCH.

Public health relevance
PROJECT NARRATIVE By using machine learning in satellite imagery and other geotagged “big data” sources, this project has the potential to fundamentally change the measurement of maternal and child health indicators in low- and middle- income countries, providing up-to-date estimates for each village and neighborhood in a country. Until now, measurement of maternal and child health has relied on household surveys, which are expensive, conducted infrequently, and cover only a small fraction of all populations and areas in a country. This research is relevant to public health because it uses an inexpensive and scalable method that could enable the geographically precise targeting of interventions and up-to-date monitoring of changes in key maternal and child health indicators, and additionally lead to a low-cost approach for evaluating the effect of past policies and interventions on maternal and child health.